Androgens modulate Staphylococcus aureus signaling and pathogenesis

Project Summary
Staphylococcus aureus soft tissue and skin infections affect seven-to-ten percent of hospitalized patients and
skin infections are the third most common reason for presentation to the emergency room. Most infections of the
skin are caused by S. aureus, with men having higher rates of infection with S. aureus compared to women.
Adding to the burden of disease posed by these pathogens has been the development of antibiotic-resistant
strains of bacteria such as methicillin-resistant S. aureus (MRSA). Despite the clear pathogenic potential of S.
aureus species, it asymptomatically colonizes the nasal passages of one-third of people. This duplicity is due to
coordinated regulatory networks that alter virulence factor expression depending on the sensed environmental
conditions. The most well-described of these is the accessory gene regulator (agr) quorum-sensing system. In
this proposal we outline our recent findings that men secrete greater amounts of testosterone at the skin surface
compared to women, and our preliminary data indicating that testosterone amplifies S. aureus virulence. Our
hypothesis is that skin secreted testosterone promotes S. aureus virulence through activation of quorum-sensing
mechanisms. To address this question, in Aim 1 we will investigate the mechanism of testosterone stimulation
of S. aureus agr signaling. We will use genetic and biochemical approaches to determine how testosterone
activates the agr regulon, and we will investigate the AgrC histidine kinase as the primary testosterone target. In
Aim 2 we will determine the impact of testosterone on S. aureus skin infection in vivo using mouse models. We
will test this phenotype using skin infection models paired with bioluminescent strains of S. aureus with and
without mutations in agr components. We will also investigate genetically engineered mice with reduced
androgen production in the skin. In Aim 3 we will identify the S. aureus enzymes that metabolize skin androgens
over time and their impact on quorum sensing. Our preliminary findings indicate that this pathogen breaks down
testosterone into androstenedione. Using bioinformatic approaches, we have identified potential androgen-
degrading enzymes encoded in the S. aureus genome and we will characterize these targets using bacterial
genetic and biochemical approaches. The work proposed in this application will determine how testosterone
regulates S. aureus pathogenesis at the skin surface and identify novel therapeutic targets for the treatment of
S. aureus.

Public health relevance
Project Narrative The proposed research is relevant to public health as Staphylococcus aureus skin infections are a common condition throughout the United States with therapeutic options limited by antibiotic resistance. Our proposed studies will determine how host-derived testosterone impacts bacterial pathogenesis and the course of skin infection and disease. This research is relevant to public health because it will help provide the basis for the development of new strategies to treat and/or prevent bacterial skin infections.